HEMATOPOIETIC POTENTIAL OF NIH-APPROVED HUMAN EMBRYONIC STEM CELL LINES

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Objective: To serve the research community by performing comprehensive characterization of hESC lines and distributing these lines and detailed technical information to investigators via the National Stem Cell Bank in Madison, Wisconsin (September 2005 through February 2010). Dr. Slukvin's role was to characterize the hematopoietic and endothelial potential of the hESC lines and subclones. This work used WNPRC Stem Cell Resources. Numerous publications relied on Dr. Slukvin's work.